Damage-Associated Molecular Patterns Driving Fibrosis Progression in Scleroderma

June 3 2018
ABSTRACT
Synchronous fibrosis in multiple organs is the defining hallmark of systemic sclerosis (SSc), but its
pathogenesis remains poorly understood, and there is an urgent need to discover “druggable” targets.
The pattern recognition receptor Toll-like receptor 4 (TLR4), a vital mediator of innate immunity, is
expressed on both immune and stromal cells, and can be activated by endogenous ligands called
“damage-associated molecular patterns” (DAMPs). Published and preliminary work from our
laboratories show that TLR4 and its endogenous ligand tenascin-C are likely to play important roles in
multi-organ fibrosis in SSc. Notably, tenascin-C itself elicits core fibrotic responses including ECM
production and matrix stiffening in fibroblasts and 3D human skin organoid models. TLR4 activity is
regulated by the ubiquitin-editing enzyme A20, which is a major risk gene for SSc. However, the
mechanism linking SSc-associated A20 variants and pathogenesis are unknown. We demonstrated
that A20 expression is reduced in SSc skin biopsies. Surprisingly, we found that A20 inhibited core
fibrotic responses, and mice that are haploinsufficient for A20 showed markedly aggravated non-
inflammatory skin fibrosis. We hypothesize that persistence of fibrosis in SSc could be explained by
activated TLR4 signaling that is triggered by tenascin-C and other DAMPs, and chronically sustained
by impaired A20 function. The cell types with increased profibrotic TLR4 pathway activity, and the
ensemble of profibrotic DAMPs and specific domains, remain unknown. Moreover, the clinical
correlates of reduced A20 in SSc, cell type-specific regulation and anti-fibrotic activity of A20, and the
mechanisms linking reduced A20 and SSc pathogenesis, have never been investigated. To address
these critical gaps, Aim 1 will determine cell type- and stimulus-specific roles and mechanisms of
DAMP-TLR4 signaling in two separate models of experimentally-induced multi-organ fibrosis; map
key tenascin-C domains and identify additional DAMPs as potential SSc biomarkers and therapeutic
targets; Aim 2 will define the clinical correlates of A20 expression in a longitudinal cohort of SSc
patients; and define distinct functions of A20 in the fibrotic process using novel A20-deficient and A20
humanized BAC transgenic mice. Aim 3 will determine the cellular sources and function of TLR4
signaling pathway activity in skin and lung from SSc patients and controls. Employing human disease
samples from the established Northwestern and Yale Scleroderma Programs, combined with in vitro
and in vivo disease models and state-of-the-art technologies including comprehensive matrisome
analysis and unbiased single cell RNA sequencing of multiple tissue, our investigative team is poised
to generate notable advances in understanding TLR4 signaling in SSc. The information in turn will
guide discovery of novel biomarkers and therapies.

Public health relevance
PROJECT NARRATIVE Systemic sclerosis (SSc) is associated with synchronous fibrosis in multiple organs. This proposal aims to test the novel hypothesis that innate immune receptors activated by damage-associated molecular patterns (DAMP) in their ECM microenvironment drive tissue fibrosis. Our studies will shed new light on cells, molecules and mechanisms of fibrosis in SSc, and identify novel treatment opportunities.